23rd Midwest DNA Repair Symposium

Abstract
The 23rd Midwest DNA Repair Symposium (MDRS) will take place in Louisville, KY on June 1-2, 2024 at
the Health Science Campus of the University of Louisville. The MDRS started in 1999 at the University of
Michigan – Ann Arbor and has met at various universities in the Midwest every year since then except for
a 3-year hiatus imposed by the COVID19 pandemic. The Midwest DNA Repair Symposium was originally
conceived as a forum to bring together DNA repair researchers from the Midwestern region on an annual
basis to discuss ongoing research, to stimulate collaborations, and to interact with leading DNA repair
researchers in an informal atmosphere. In 2024, we will have 3 eminent DNA repair researchers as keynote
speakers continuing the history of leading researchers gladly accepting the invitation. Additional goals of
the MDRS include making the cost of attending the symposium as inexpensive as possible and to provide
early stage investigators, postdoctoral fellows and graduate students priority in presenting their work in
oral and poster sessions. DNA repair is a fundamental cellular process critical to maintenance of genome
integrity and human health. DNA repair dysfunction has been linked with many inherited diseases as well
as chronic diseases such as cancer, neurodegeneration, cardiovascular disease, and aging. The
organizers are pleased that this symposia series has been very successful and has seen significant
increase in attendance the past several years. One key to the success has been to keep the costs of
attendance low. This low cost has been possible because the organizers for each year held the symposium
at their home institutions and have secured both intramural and extramural funding to cover some of the
major expenses. Especially in times of restricted research funding, the MDRS is one quality conference to
which PI’s have been able to bring their students and post-doctoral fellows to interact with leading scientists
in the field and to present their work among peers. To celebrate its 25th anniversary the MDRS is returning
to Louisville for the third time in 2024. The three principal goals of the MDRS are: 1) to provide a venue for
scientists mainly but not exclusively, from the Midwestern States to present and discuss current research
in the field of DNA damage, repair and mutagenesis, and to provide opportunities to foster scientific
collaborations. (2) To provide students, postdoctoral fellows, and early stage investigators the opportunity
to present their work to peers and to interact with leaders in the field. (3) To provide an exceptional value
of these symposia by keeping them affordable.

Public health relevance
Project Narrative DNA damage contributes to the development and progression of chronic human disease including cancer, cardiovascular, neurodegenerative diseases and aging. DNA repair is an essential cellular processes that removes the DNA damage and efficient DNA repair is essential to prevention of these chronic diseases. This symposium will bring together DNA repair researchers to discuss their newest research, to exchange ideas and to develop new collaborations.